2019 Mycotoxin and Phycotoxin Gordon Research Conference and Gordon Research Seminar

THE 2019 GORDON RESEARCH CONFERENCE AND GORDON-KENAN SEMINAR ON MYCOTOXINS AND PHYCOTOXINS The Gordon Research Conference (GRC) on Mycotoxins and Phycotoxins -Risk and Regulation in a Multi-toxin Exposure World, provides an international forum for the presentation and discussion of emerging research on fungal, algal, and cyanobacterial toxins, their effects on human and ecosystem health, and the biology and ecology of the organisms that produce them. This multidisciplinary gathering will convene at Stonehill College in Easton, Massachusetts, on June 16-21, 2019. The goals of the conference are to assemble both established and developing scientists in an atmosphere that facilitate creative interdisciplinary thinking to advance knowledge of the complex problems presented by these naturally occurring organisms and their toxins. Considerable effort is made to provide participants, outstanding scientists and aspiring students alike, the opportunity to interact in relaxed surroundings that promote the free exchange of ideas on a whole host of different topics. Themes to be explored at the 2019 conference include: (1) efforts in monitoring, mitigation and forecasting prevalence, (2) exposure risks and vulnerable populations, (3) increased prevalence and economic impacts, (4) human health and early developmental effects, (5) microbial community dynamics and biotoxin production, (6) co-occurrence and combined toxicity, (7) metabolomic approaches and new described toxins, (8) regulation and biosynthesis, a Keynote presentation on challenges in low and middle income countries. The conference is unique in that it brings together a diverse multi-disciplinary group of research scientists and students who are all ultimately focused on solving similar problems, albeit coming at them from many different directions. They are united by a common desire to ensure the health of the environment and the safety and security of our food and water supply. In addition to the GRC, a Mycotoxins & Phycotoxins Gordon-Kenan Research Seminar GRS- Deciphering Biotoxin Production, Cell Mechanisms and Mitigation in a Changing Environment, immediately precedes the GRC on June 16-17, 2019. Organized and conducted by graduate students and young investigators, the GRS will enable junior scientists to formally present their work to an audience of peers. These students and post-doctoral fellows will subsequently participate in the Mycotoxins and Phycotoxins GRC, providing them with an unmatched opportunity to build relationships between their peers and with established scientists.

Public health relevance
Project Narrative Fungal toxins (mycotoxins), algal toxins (phycotoxins) and cyanobacterial toxins are major sources of food-borne and water-borne intoxications to humans, agricultural animals, domestic pets and wildlife. Safeguarding the public requires an understanding of their sources (especially increasing prevalence in the environment), and their chemistry and toxicology. The Gordon Research Conference on Mycotoxins and Phycotoxins provides an international, interdisciplinary forum for the discussion of emerging research on these toxins.